Impacts of Sleep and Circadian Biology on Alzheimer's Disease and Aging: A Focus on Genetics and Genomics

PROJECT SUMMARY
An emerging area of investigation is the relationship between aging, sleep and circadian rhythm, and Alzheimer’s
disease (AD) progression. For example, the AD hallmark of Aβ aggregation is associated with changes in sleep-
wake patterns and circadian-related metabolism. As these changes occur years prior to clinical manifestations
of AD, they may be early events in AD. To understand this relationship, the fields of sleep/circadian biology and
AD are taking similar strategies that include genetic and biomarker studies in humans and model organisms
such as the mouse, and research is converging on recent advances in genomic technologies (e.g., single-cell
RNA-seq and epigenomics) that allow more precise description of molecular and cellular changes that occur as
a function of age, sleep/circadian rhythm, and AD progression. As studies in these fields are at the nascent and
critical stage of intersection, we recognize an unmet need for investigators in sleep/circadian biology to learn
from their colleagues in AD, and vice versa. Currently, no conference in the aging/AD field incorporates
sleep/circadian biology, let alone focuses on genetics, genomics, and computational biology approaches. To fill
this gap, we propose the unique and timely interdisciplinary conference “Impacts of Sleep and Circadian Biology
on Alzheimer’s Disease and Aging: a Focus on Genetics and Genomics” to ignite interactions among a focused
group of scientists and trainees from these fields and to foster future collaborations. We propose an annual,
intensive 3-day conference beginning in October, 2021 at The Jackson Laboratory in Bar Harbor, ME. We will
bring together 50 scientists -- graduate students, postdoctoral fellows, and junior and senior investigators -- from
the fields of aging/AD, neurodegeneration, genetics of sleep/circadian biology, genetics, and computational
biology. In Aim 1, we will organize this interdisciplinary conference on sleep/circadian biology and AD with a
focus on genetic and genomic approaches. Invited speakers and session topics will represent a variety of
disciplines that aim to solve questions related to AD. Each day a morning seminar will introduce trainees in the
AD field to the fundamentals of sleep/circadian biology and advanced computational approaches in genetics and
genomics while a hands-on afternoon workshop will focus on 'omics' analyses to spur the trainees' own research.
In Aim 2, we will promote interactions that foster collaborative research and career advancement. We will include
breaks and a poster session as opportunities for free-form discussions as well as devote one workshop to career
development, including grantsmanship and ethics. To foster inclusive and creative science, in Aim 3 we will focus
on recruitment of diverse attendees, utilizing our partnership societies and networks to recruit underrepresented
minority and disadvantaged attendees, as well as offering scholarships to those who qualify and are in need. We
anticipate that the conference and workshops will cross-pollinate the fields of sleep/circadian biology and AD
and seed new collaborations while equipping the next generation of AD and sleep/circadian biology researchers
with the ability to harness advanced computational approaches in their research.

Public health relevance
PROJECT NARRATIVE / RELEVANCE TO PUBLIC HEALTH Emerging evidence indicates that sleep disturbances occur early in the development of Alzheimer’s disease (AD), but the significance of this observation is only beginning to be understood by researchers. Thus, to accelerate our understanding of the relationship between sleep disturbance and AD, we propose to hold a scientific conference that will bring together junior and senior researchers who study AD, aging, and sleep/circadian biology and computational biologists who have experience in integrating data from genetic and genomic studies. The conference will train junior investigators in state-of-the-art technical approaches for conducting studies in humans and laboratory mice that can define the cellular changes that result from sleep changes, age, and the progression of AD, with the ultimate hope of developing new treatments that can slow AD progression.